Deciphering Mechanosignaling Using Multi-fluorescence Biomembrane Force Probe

Project Summary/Abstract
This R35 proposal represents a comprehensive program that dives into the understanding of mechanosignaling,
while providing training and mentorship to young scientists. The principal investigator (PI) has over a decade of
experience in molecular and cellular mechanobiology in the context of both basic science and translational
research. A major gap in the current field of cellular and molecular mechanobiology is that the scientific
discoveries are difficult to translate to improve disease diagnosis and treatment, which is partially due to the lack
of an effective approach to understand the inner works of mechanosignaling. Taking advantage of the R35 grant
mechanism, this program will develop a methodology framework that can decipher principles and
mechanisms of mechanosignaling at the sub-molecular level, which is achieved by combining a cutting-
edge force spectroscopy platform we developed in house—the multi-fluorescence biomembrane force probe
(MF-BFP)—with other in vitro and in silico approaches such as molecular and cellular engineering, super-
resolution imaging, biophysical modeling, and molecular dynamics simulation. Integrins, an important family of
cell mechanoreceptors, are selected as the molecular model for study due to their profound importance in general
physiology and pathology. Seminal concepts under two themes will be explored. Firstly, under the theme of single
receptor mechanosignaling, we will study the principles and mechanisms of how single integrins receive, transmit
and transduce mechanosignals. We will identify ‘hotspots’ in the integrin structure that mediate integrin
mechanosensitivity in ligand binding and conformational changes. By manipulating these hotspots via
mutagenesis to directionally and finely tune the integrin mechanosensitivity, we aim to quantitatively manipulate
the principles of single integrin mechanosignaling. Secondly, under the theme of receptor cis/trans-crosstalk in
mechanosignaling, we will first investigate how two or more integrins cooperate to trigger mechanosignals on a
single cell. Next, we will move into a new direction related to the intriguing phenomenon of ‘cell handshaking’,
where we will assess the bi-directional biomechanical signal communication between two cells. Collectively, this
program will provide in-depth insights into integrin-mediated mechanosignaling and inspire novel strategies for
developing integrin-targeting mechanomedicines. Furthermore, the program is anticipated to establish the
method and provide the know-how for deciphering mechanosignaling that are applicable to most, if not all,
molecular and cellular systems. The widely application of our MF-BFP-centered methodology framework will
allow us to better understand mechanobiology-related pathology in various diseases and more efficiently develop
mechanobiology-inspired diagnostics and therapeutics in the future. To secure the success of the proposed
research, this program will be supported by a strong network of collaborators within and outside of the PI’s home
institute.

Public health relevance
Project Narrative Mechanobiology, which describes how cells and tissues sense and respond to biomechanical stimulations, plays a critical role in the pathogenesis of many prevalent and life-threatening diseases. However, the current field of mechanobiology is deficient in translating scientific discoveries to improve disease diagnosis and treatment, which is partially due to the lack of an effective strategy to understand the inner works of mechanosignaling. By studying integrins as the molecular model, this proposal will showcase a new methodology framework that combines our unique technology multi-fluorescence biomembrane force probe with other in vitro and in silico approaches, which can decipher the in-depth principles and mechanisms of mechanosignaling, ultimately paving the way for developing mechanobiology-inspired diagnostics and therapeutics.